Super-Resolution Fluorescence Microscopy of Synaptic Plasticity on Unmodified Brain Slices in Health and Tauopathy

Neuronal communication occurs at intercellular junctions called synapses, which can dynamically strengthen
and weaken — termed synaptic plasticity. While synaptic plasticity underlies learning and memory, abnormal
plasticity is associated with synapse loss and memory decline. Synaptic plasticity is expressed, in part, by
changes in the level of glutamate-gated AMPA receptors (AMPARs). The distance scale is ~10-25 nm, and thus,
~10 nm resolution is needed to ascertain structures like nanodomains and nanocolumns. Measuring such
changes at the nanometer level in native brain slices is difficult due to the extraordinary high density of cells and
proteins, particularly in the hippocampus. While many super-resolution fluorescence microscopy (SRFM) tech-
niques (most commonly dSTORM) exist to image AMPARs in dissociated neuronal culture, very few have been
applied with high resolution to brain slices: the ones that do, look only near the edge (a few µm deep) or use
knock-in mice of epitope-tagged subunits. In addition, methods to decrowd proteins, such as expansion and
clearing, involve extensive tissue manipulation. As a result, SRFM on unmodified brain slices is considered the
‘gold standard’. The goal of this technology proposal (PAR-22-127) is to develop new forms of SRFM that can
isolate native surface AMPARs in both synaptic and non-synaptic domains during synaptic plasticity on unmod-
ified brain slices as a function of health and tauopathy that cause memory loss. To identify synaptic vs non-
synaptic AMPARs on the cell membrane necessitates multi-color SRFM techniques to define the spatial resolu-
tion of synaptic proteins surrounding surface AMPARs. In our unpublished work, we selectively labeled native
AMPAR subunits GluA2-4 on the cell surface of live 200 µm thick brain slices using a small chemical labeling
agent called CAM2-Alexa647. After fixation and sectioning to ~30 µm, the slices were labeled on the postsynaptic
protein, Homer1, with a second SRFM dye (CF568). AMPAR and Homer1 were then imaged using two-color 3D
dSTORM with an aberration corrected microscope and deformable mirrors, resulting in 20x20x90 nm 3D reso-
lution on a native brain slice. This has not previously been accomplished. In Specific Aim 1, we will extend this
work to achieve 3-color SRFM with ~ 11 x 11 x 40 nm resolution to determine AMPAR distances from Bassoon
or RIM1 in the presynaptic terminal, thereby identifying synaptic vs non-synaptic AMPARs. Hyperphosphorylated
tau will be labeled with a 4th SRFM color. A new self-interferometric SRFM technique, called SELFI, along with
3D-dSTORM, will also be used with the goal of simplifying the optics. In Specific Aim 2, we aim for an improved
resolution (< 10 nm) by serially slicing the native brain slices into “thin” sections (0.7~4 µm) and digitally recom-
bining their images to the original thickness. Equipped with new cameras, lasers, fluorescent dyes, and software,
we expect a 30-100-fold speed improvement, possibly extending 3D dSTORM and SELFI to other parts of the
brain. We will validate these techniques in well-established systems for surface AMPAR change including hip-
pocampal synaptic plasticity, fear-induced learning, and tauopathy.

Public health relevance
Project Narrative The goal of this project is to construct a new super-resolution microscope that can image how native neurons change with synaptic plasticity—specifically, how nerves change in mice from external learning and fear conditioning. The neurons are labeled with a special fluorescent dye, sectioned into slices, and then imaged with an additional three dyes. Nanometer resolution is possible.